Proteotoxic Metabolites in Genome Instability and Disease

Summary
Diverse exogenous and endogenous aldehydes produce aberrant adducts that, if left unrepaired, can promote
genome instability and disease. Prevalent lifestyle choices as well as intrinsic metabolic dysfunctions and
genetic exposures associated with cancer and aging have been linked to the accumulation of reactive
aldehydes that produce persistent, genome-destabilizing DNA adducts. Inactivation of aldehyde clearance and
DNA repair proteins leads to genome instability and cancer by rendering cells hypersensitive to formaldehyde-
and acetaldehyde-induced DNA damage. Genotoxic DNA adducts are considered the de facto surrogates for
aldehyde-related genome instability. However, another less studied mechanism of genome instability is defects
in the folding of DNA repair proteins. In addition to damaging the DNA, aldehydes also modify proteins to
produce aberrant protein adducts that cannot fold or function properly. Yet, the role of proteotoxic stress in
aldehyde-induced genome instability remains enigmatic. Here, we hypothesize that aldehyde derived protein
adducts target the central protein folding chaperone heat shock protein 90 (HSP90) in impairing the folding of
critical DNA repair proteins that regulate genome stability. Our published finding that HSP90 can buffer (that is,
mitigate) deleterious mutations in humans provided a system to compare side-by-side both the genotoxic and
proteotoxic effects of aldehydes in cells and tumors. Using this system in preliminary work, we now show that
mutations that HSP90-buffered mutations in DNA repair genes render genome instability conditional upon
seemingly benign exposures to formaldehyde and acetaldehyde. The goal of the proposed research is to
unravel mechanisms of HSP90-contingent genome instability elicited by reactive aldehydes. The rationale for
this proposal is that understanding how aldehydes promote genome instability may reveal new universal
approaches for risk stratification and management. This project will achieve this goal by employing innovative
adductomics and functional genomics approaches strategically designed to 1) determine the mechanism of
HSP90 impairment by formaldehyde and acetaldehyde, and 2) delineate the proteotoxic and genotoxic effects
of aldehydes on genome instability in tumor xenografts. The successful completion of this project will define
mechanisms linking genome instability, proteotoxic stress, and metabolic dysregulation, cellular hallmarks of
disease that are traditionally studied in isolation. The proposed work will also evaluate protein adducts as
comprehensive indicators of proteotoxicity and will probe the role of aldehydes as the ecological stressors that
engage HSP90 function in driving genome instability in cells, tissues, and tumors. Achieving this will provide a
framework and new tools for future studies to decipher gene-by-metabolite-by-environment relationships and to
develop more efficacious individualized strategies for managing diverse aldehyde-related diseases, including
many cancers.

Public health relevance
PROJECT NARRATIVE This project will define mechanisms of proteotoxicity underlying the genome instability phenotypes caused by reactive aldehydes that accumulate in cancers and diverse other age-related diseases. Insights from its findings will identify useful targets for the prevention and management of aldehyde-related diseases and may provide novel biomarkers of proteotoxicity and genome instability for biomonitoring, early diagnosis, and risk stratification.